RR&D Research Career Scientist Award Application

Dr. Bell is requesting renewal of his SRCS for an additional 5 years at which point Dr. Bell will have 47
years of VA service. During these 5 years he plans to continue to vigorously pursue his research, education,
administrative and service mission.
Dr. Bell has been involved in VA rehabilitation research for four decades. During that time he has
helped shape the field of vocational rehabilitation and cognitive remediation, and many of his innovations have
been adopted into clinical practice and have inspired new research by investigators nationally and
internationally. His research has focused on 1) vocational rehabilitation, 2) neurocognitive and social
cognitive deficits and their relationships to functional impairments, 3) development of assessment
instruments, 4) cognitive remediation, and 5) substance abuse rehabilitation. He has a consistent record of
successful research with funding from VA RR&D, NIMH, NIDA, DoD and NSF. Currently, he is principal
investigator of a new VA RR&D MERIT grant, a new NSF grant, a NIMH research training grant, and a current
DoD grant. Dr. Bell plans to continue to work on these currently funded grants during the period of this
proposed renewal of his SRCS. He hopes that findings from his currently funded projects will serve as the
foundation for future grant submissions.
Dr. Bell also plans to continue his scientific contributions in terms of publications and presentations.
During his current SRCS funding, he has published 44 peer reviewed articles, 5 book chapters, 1 new testing
instrument (Social Attribution Test-Multiple Choice) and has given more than 40 scientific presentations. Two
of Dr. Bell's contributions to assessment are used nationally and internationally in psychiatric clinical trials and
are regarded as the “gold standard” for measuring work performance and for measuring social cognition. One
indication of his status as a leader in psychiatric rehabilitation is that he was recently selected by the World
Health Organization to be one of three USA psychiatric rehabilitation experts for their 24-member international
panel for the development of the International Classification of Functioning, Disability and Health (ICF-11) and
was then selected to be one of 4 team leaders on the project.
Dr. Bell is an accomplished educator and mentor in his field with more than 48 mentees during his
career, many of whom have gone on to independent research careers. Fourteen are currently working for the
VA. In 2001, Dr. Bell was awarded a prestigious training grant (NIMH T32) to provide training to clinicians to do
research in functional disability interventions. This award has been twice competitively renewed because of its
significant impact on bringing young and promising investigators into the field of rehabilitation. He plans to
continue these activities during the next period of his SRCS.
Dr. Bell has provided significant administrative service to the VA by assuming the considerable
responsibilities of being Chairman of the Human Studies Subcommitte.at VACHS. He also has served on 18
review panels for VA RR&D and NIMH during his current SRCS and plans to continue these efforts on behalf
of the VA research mission.
Finally, Dr. Bell continues to provide direct service to Veterans. During this current SRCS period, Dr.
Bell began an outreach effort to college Veterans (Veteran Integration To Academic Leadership - VITAL) at
VACHS and is providing direct clinical and psycho-educational assessment services with a small team that he
manages. They are currently serving 7 area universities, and during the proposed renewal of his SRCS
period, he plans to continue to expand this project.

Public health relevance
Dr. Bell is requesting renewal of his SRCS for an additional 5 years. During these 5 years he plans to continue to vigorously pursue his research, education, administrative and service mission. Dr. Bell has an international reputation in psychiatric rehabilitation and is currently funded by VA RR&D, DoD, NIMH, and NSF. Renewal will allow him to continue his research in 1) vocational rehabilitation, 2) neurocognitive and social cognitive deficits and their relationships to functional impairments, 3) development of assessment instruments, 4) cognitive remediation, and 5) substance abuse rehabilitation. These research activities meet priority healthcare needs for Veterans. Dr. Bell plans to continue his mentorship to train the next generation of clinical researchers, to continue to provide administrative support to the VA research mission by chairing the Human Studies Subcommittee and by serving on VA RR&D review groups, and to continue to directly serve Veterans as Director of an outreach program to Veterans on area college campuses.